Cognition and Hippocampal/Cortical Systems in Aging

The hippocampus and medial temporal lobe structures play critical roles in declarative memory. Because memory loss is one of the hallmark characteristics of normal and pathological aging, a key challenge is to understand the physiological changes that occur in the hippocampus with aging. Recent results suggest that the lateral entorhinal cortex (LEC) is particularly susceptible to age-related dysfunction. Moreover, treatment with the antiepileptic drug, levetiracetam, can ameliorate some of the physiological and cognitive impairments associated with aging. This project proposes experiments to test specific hypotheses about how LEC and the medial entorhinal cortex (MEC) affect hippocampal function with aging. Place cells of aged rats with impaired memory show a reduced control by local sensory cues (associated with the LEC), whereas they continue to be controlled by global spatial cues (associated with the MEC). Place cells of the CA3 region will be recorded in the following experiments. (a) Local and global spatial reference frames will be placed in conflict. It is hypothesized that aged impaired rats will show an abnormal lack of control by the local reference frame, and that this abnormal condition will be ameliorated by treatment with levetiracetam. (b) The geometry and location of a recording chamber will be altered. It is hypothesized that aged impaired rats will show an abnormal stability of their place fields when only the geometry is altered (due to a loss of LEC input) but will show normal place field changes when the location is altered (due to normal MEC input). The abnormal stability patterns will be ameliorated with levetiracetam treatment. (c) The formation of new place fields associated with an investigatory behavior known as head- scanning will be investigated It is hypothesized that aged impaired rats will show a reduction in the formation of new place fields. Treatment with levetiracetam will restore this neural plasticity phenomenon. (d) Recordings from the MEC and LEC will test the hypothesis that grid cells, border/boundary cells, and nonspatial cells of aged impaired rats will be normal, compared to young and aged unimpaired rats. These experiments will provide robust tests of the hypothesis that LEC neural processing is particularly susceptible to age-related dysfunction, and that levetiracetam treatment is a potential therapy to restore hippocampal function in aged-impaired animals.

Public health relevance
Aging is often accompanied by cognitive deficits and is also the major risk factor for Alzheimer's disease. This multi-component research program studies a rodent model of naturally occurring variation in cognitive aging, with the goal of understanding the neurobiological basis of impairment and preservation of brain function. Building on existing therapeutic progress, work within this program will continue to contribute to the development of effective therapeutic interventions for cognitive decline in aging.